The function of LIN28B and follistatin in supporting cell reprogramming and hair cell regeneration in the murine cochlea

Project summary
Our proposed study aims to address the function of LIN28B and follistatin in supporting cell reprogramming and
hair cell regeneration in the murine cochlea. Loss of auditory hair cells (HCs) due to disease or trauma is
permanent and is a leading cause for hearing impairments and deafness in humans. Immature auditory
supporting cells (SCs) do regenerate HCs in response to damage but their ability to regenerate lost HCs rapidly
declines as SCs undergo maturation and little to no HC regeneration is observed in adult animals. We recently
uncovered that the RNA binding protein LIN28B and its paralog LIN28A control the regenerative capacity of
cochlear SCs in neonatal cochlear organoids and explants. Whether LIN28A/B has a similar role in cochlear HC
regeneration in vivo has yet to be tested. Furthermore, our recent in vitro studies suggest that LIN28B promotes
HC regeneration through reprogramming SCs into progenitor-like cells and that such state transition can be
further enhanced by the co-activation of the Activin antagonist follistatin. However, whether SCs truly activate a
transitional progenitor-like state during HC regeneration and if so, how LIN28B and FST may influence such
state transition are still unresolved. In our proposed study we will use mouse genetic tools to address whether
LIN28A/B regulates spontaneous cochlear HC regeneration in the immature cochlea in vivo (aim1). Furthermore,
we will use single cell RNA sequencing and single molecule FISH to determine whether LIN28B reprograms
cochlear SCs into progenitor-like cells during HC regeneration (aim2). Moreover, to establish how LIN28B and
FST enhance SC reprogramming and subsequent HC regeneration we will manipulate the function of potential
LIN28B and FST effector genes using lentiviral overexpression and CRISPR-Cas9-mediated knockout strategies
in cochlear organoids (aim3). Finally, we will determine whether co-expression of LIN28B and FST with Atoh1
enables SCs to regenerate cochlear HCs in the mature cochlea in vivo (aim4).

Public health relevance
Project narrative Mechano-sensory hair cells within our ear are essential for our ability to detect sound. Hair cells are not regenerated and their loss is a leading cause for deafness in humans. In our proposal, we will investigate whether re-activation of the progenitor-specific genes Lin28b and follistatin will enable supporting cells to re-activate a progenitor-like state and allow them to regenerate lost hair cells. We anticipate that insights gained from our study will provide exiting new avenues for cell-based hearing restoration efforts.